Astrocyte Network Facilitation of Neuroplasticity

Project Summary/Abstract
Astrocyte gap junctions are necessary for memory formation, synaptic plasticity, coordination of neuronal
signaling, and closing the visual and motor critical periods; we also know signaling through astrocyte gap
junctions can drive changes between behavioral states. Studies on networks of gap-junction-connected
astrocytes have been limited to in vitro methods, slice electrophysiology, and pan-astrocyte
knockouts. However, these methods cannot deeply examine the complexity and function of distinct, 3D, in
vivo astrocyte networks, and largely limit mechanistic work to calcium dynamics. However, studies in other model
systems have found that gap junctions flux many molecules known to facilitate neuroplasticity – especially
connexin 43 (cx43), which has the largest pore limit and is the predominant astrocyte connexin. To
address this gap in neuroscience, I designed and built a vector that marks functional astrocyte networks by
biotinylating molecules fluxed by an infected astrocyte's gap junctions. Using a tissue-clearing method I
optimized to preserve astrocyte morphology, I was able to map functional astrocyte network communication
across whole, cleared brains. I found that there are many independent astrocyte networks across the brain, each
connecting specific brain regions rather than diffusing indiscriminately. Through mass spectrometry, I also
identified over 200 biotinylated metabolites, antioxidants, and peptides that traverse astrocyte networks. I will
now build on these findings to test a central hypothesis: astrocyte networks circulate pools of antioxidants that
buffer oxidatively stressed local environments and facilitate neuroplasticity. I will study neuroplasticity in adult
mouse barrel cortex induced by whisker trim, a robust model of neuronal remodeling. Using my vector, I
found that astrocyte networks usually connect several brain regions. However, barrel cortex astrocyte networks
are almost exclusively limited to barrel cortex itself. This makes barrel cortex an optimal system to establish the
fundamental organizational and mechanistic properties of astrocyte networks. Here, I first use state-of-the-art
spatial transcriptomics and mass spectrometry imaging to establish the fundamental organizational
properties of astrocyte networks. I then use chemogenetics in neurons to challenge broad astrocyte networks
to functionally adapt to extremes in local environments and determine mechanisms by which astrocyte networks
support the varied needs of the multiple brain regions they traverse. Finally, the first experiments in my
independent laboratory will manipulate astrocyte network wide antioxidant pools to determine if these pools can
rescue neuronal remodeling during periods of oxidative stress, then eliminate astrocyte networks in the brain to
determine if antioxidant support is the sole way astrocyte networks support remodeling neurons. Together, these
experiments provide a foundational understanding of astrocytic networks while exposing mechanisms necessary
for neuronal plasticity to occur.

Public health relevance
Project Narrative Astrocyte networks are required for memory consolidation, facilitate plasticity, and represent the brain's endogenous defense mechanism against neurodegeneration - all vital functions, but the fundamental properties of these intracellular networks are not understood. Here, I have developed a tool that allows us to see, for the first time, individual astrocyte networks in fully transparent, intact brains and finally begin to understand how these networks communicate. The proposed research capitalizes on this development to establish fundamental properties of astrocyte network structure and function during cortical plasticity, with our findings having potentially far-reaching implications on our ability to enable brain regeneration after injury or disease.